Inflammasome and unstable atherosclerotic plaques

Cigarette smoking is a major independent risk factor for cardiovascular disease. Among over 4,000
chemicals in tobacco smoking, nicotine, the primary addictive agent in cigarettes, is one of the major
component of tobacco smoke. Nicotine is also the major constituent in electronic cigarettes (EC) -
which are becoming popular as an alternative to smoking tobacco. Although there is overwhelming
epidemiological evidence linking smoking, nicotine, and cardiovascular diseases, there is no direct
evidence showing that nicotine instigates atherosclerotic plaque instability (so called rupture). A
causative link of smoking and plaque instability remains to be established. We have obtained exciting
preliminary data demonstrating that infusion of smokers-relevant concentrations of nicotine promoted
atherosclerotic plaque instability in our well-characterized mouse models in vivo. Nicotine not only
dramatically elevated serum level interleukin 1 (IL-1)β but also obviously upregulated NALP3
inflammasome complex components and IL-1β in advanced atherosclerotic plaques. In addition, the
inhibition of caspase 1, a key downstream target of NLRP3 inflammasome complex, restrained nicotine-
stimulated atherosclerotic plaque formation and plaque rapture. Thus, the central hypothesis of this
application is that nicotine in smoking promotes atherosclerotic plaque rapture by activating
inflammasome in vascular smooth muscle cell (VSMC). To validate or refute this hypothesis, we
propose three aims: Aim 1 is to evaluate and compare the impacts of nicotine alone and electronic
cigarettes exposure on atherosclerotic plaque instability and IL-1β levels in our well-characterized
mouse models in vivo and in autopsy samples of human smokers and non-smokers. Aim 2 is to define
the contributions of NLRP3 inflammasome activation and IL-1β in nicotine- and electronic cigarettes -
induced atherosclerotic plaque instability, identify whether IL-1β is a trigger for plaque instability in
smokers. In this aim, we will examine the role of NLRP3 inflammasome in regulating nicotine- or EC-
induced plaque instability by using NLRP3-/-Apoe-/-, ASC-/-Apoe-/-, Caspase1-/-Apoe-/- mice. We will also
perform administration of IL-1β neutralizing antibody in vivo to study whether blocking of IL-1β will
reverse nicotine- and electronic cigarettes-induced plaque instability. Finally, VSMC-specific NLRP3
knockout mice in Apoe-/- background will be generated and challenged with nicotine and electronic
cigarettes to study the contribution of VSMC-derived NLRP3 inflammasome activation in nicotine- and
electronic cigarettes-induced atherosclerotic plaque instability. Aim 3 is to determine how nicotine
activates NLRP3 inflammasome in VSMC. The completion of this study will unveil the molecular insights
by which nicotine effect on atherosclerotic plaque instability, and identify IL-1β as a novel therapeutic
target for nicotine- or electronic cigarettes-induced plaque instability.

Public health relevance
Although there is overwhelming epidemiological evidence linking smoking and cardiovascular diseases and stroke, a causative link between smoking and atherosclerotic plaque rapture remains to be established. The goals of this application is to determine if nicotine, a major constitute in tobacco smoke and electronic cigarette, instigated atherosclerotic plaque rapture by activating vascular smooth muscle-derived NLRP3 inflammasome and if anti-inflammasome therapy ablates atherosclerotic plaque rapture, coronary heart disease, and strokes.